Developing Cone-Dominant Retinal Disease Models as a Resource for Translational Vision Research

PROJECT SUMMARY/ABSTRACT .
The NEI’s Audacious Goal Initiative (launched in 2012) put forward the challenge of “restoring usable vision in
humans by regenerating neurons and neural connections in the eye and visual system.” While there is an obvious
affinity towards novel therapies, current resource and technology gaps preclude translation of many therapeutic
approaches. One such gap pertains to the availability of animal models that share key features of human retinal
anatomy, as well as disease models that faithfully emulate the mechanisms and processes seen in patients with
retinal degenerations (blinding diseases that might be amenable to regenerative therapies). The absence of
readily available cone-dominant mammalian models represents a major technology gap impeding efforts
to develop and evaluate regenerative treatment strategies in the retina. We propose to advance two
promising model systems that are closer to human visual anatomy and function than the more widely used
mouse and rat models. The first is the 13-lined ground squirrel (13-LGS): a diurnal, cone-dominant rodent (~85%
cones) with large brain regions dedicated to processing visual information. The second is the tree shrew: a non-
rodent, primate-like mammal that is also cone dominant (~95% cones). These models have been used to study
visual transduction (13-LGS), outer segment morphogenesis, shedding, and remodeling during hibernation (13-
LGS), cone-bipolar cell circuitry (13-LGS), myopia (tree shrew) and central visual processing (tree shrew).
However, their use as translation-enabling models for evaluating both survival and integration of regenerated
cone photoreceptors has been limited; mainly due to a lack of tools that allow for genetic manipulation of these
animals (and thus a dearth of disease models). We propose to advance these species as disease-relevant
models through the following Specific Aims: (1) Develop, optimize, and validate imaging methods and functional
assays for the 13-LGS and tree shrew; (2) Generate 13-LGS and tree shrew cone photoreceptors from iPSCs
in vitro; (3) Create rAAV-mediated retinal degeneration models for the 13-LGS and tree shrew in vivo; (4) Enable
germline transgenic 13-LGS models of human disease; (5) Test and optimize integration of transplanted 13-
LGS, tree shrew, and human iPSC-derived cones in normal and degenerated 13-LGS and tree shrew retinas. A
key feature of this proposal is the validation of these models by comparing their cellular-resolution phenotype
with that seen in patients with similar conditions/mutations. Throughout the project, we will share and disseminate
our protocols, methods, and data to provide resources for use by the broader vision research community; this
will be done using existing and newly-created online tools. A major strength of this application is the
multidisciplinary team that has been assembled to take on this challenging project. The team brings the
necessary complementary expertise required for model development, stem cell treatment, and evaluation of cell
survival, integration, & function. This work will have a significant positive impact by providing not only validated
disease models but also generalizable tools with which to create additional models in these and other species.

Public health relevance
The NEI’s audacious goal, to “regenerate neurons and neural connections in the eye and visual system,” requires translation-enabling animal models that recapitulate human retinal disease in order to evaluate strategies to regenerate photoreceptors. Here we propose to develop, characterize and disseminate two promising model systems that are closer to human visual anatomy and function than current mouse and rat models: the 13-lined ground squirrel (diurnal, cone-dominant rodents with large brain regions dedicated to processing visual information) and the tree shrew (non-rodent, primate-like mammals that are also cone dominant). The project will first validate these models by comparing their cellular-resolution phenotype with that seen in patients with similar gene mutations, then, evaluate and optimize integration of transplanted iPSC-derived cone photoreceptors in normal and diseased 13-lined ground squirrels and tree shrews.